Novel Determinants and Measures of Smokeless Tobacco Use

DESCRIPTION (provided by applicant): Currently, there are 7.7 million smokeless tobacco users in the U.S. Smokeless tobacco use has been associated with increased risk of oral pathologies (including oral cancer), pancreatic cancer, diabetes and other components of the metabolic syndrome, fetal toxicity and possibly cardiovascular disease. The extent of these health risks may be associated with the amount of toxicants in these products and the extent of exposure to these toxicants. Research has shown wide variability in carcinogens as well as nicotine in these products. The WHO Framework Convention on Tobacco Control and the proposed FDA legislative bill for tobacco product regulation have provisions that would require tobacco companies to reduce or eliminate harmful toxicants and to reduce levels of nicotine. However, very little research is available to guide decision makers on the impact of reducing toxicants and nicotine nor do we completely understand factors other than product toxicity that are associated with the extent of toxicant exposure. Two studies are proposed with the following goals: 1) Study 1 will examine brands of U.S. smokeless tobacco (ST) products that contain different levels of tobacco specific nitrosamines (TSNAs), other carcinogens and nicotine on existing and novel biomarkers of exposure and effect. In addition, this study will comprehensively determine factors that moderate the extent of exposure other than the levels of toxicants in these products. These factors include individual, social and environmental influences. Subjects will be recruited from 3 different regions in the U.S. and will be assessed on two different occasions. This study will contribute new information on critical factors associated with toxicant exposure. 2) Study 2 will determine the effects of switching ST users to lower TSNA and high, moderate or low nicotine ST products on pattern of use, biomarkers of exposure and toxicity, and facilitation of abstinence. Subjects will undergo measurements during use of their usual brand of smokeless tobacco and then switch to the assigned product for 12 weeks, with follow-up at week 13 and 26. This study would demonstrate the feasibility and impact of switching ST users to less toxic ST products. Together, these studies will help to guide important policy decisions to reduce the toll of tobacco-related disease.

Public health relevance
Project Narrative The proposed studies will inform decision makers of science-based policies that can reduce levels of exposure to smokeless tobacco toxicants in smokeless tobacco users and potentially reduce tobacco-related harm by facilitating cessation. Furthermore, these studies will provide a better understanding of factors other than product constituents in tobacco products that might influence the amount of exposure to toxicants. Finally, the proposed studies will provide measures and methods that can be used to assess tobacco products in the event of tobacco product regulation. __SpecificAimsTextDelimiter__ A. Specific Aims Reducing toxicants in tobacco products and establishing performance standards for tobacco products have been discussed and recommended by the World Health Organization Tobacco Regulation Study Group and by tobacco control scientists and advocates [1, 2]. Although the focus to date has been primarily on cigarettes, reducing tobacco toxicants in smokeless tobacco should also be strongly considered and recommended [3]. The extent of toxicity varies considerably across different brands of smokeless tobacco (ST) products and data suggest that greater toxicity may result in greater health risks. However, little is known about the actual extent of human exposure to toxicants from current ST products and factors that might moderate the extent of this exposure. Furthermore, little is known about the best methods (including manipulating free nicotine levels) to reduce ST toxicant exposure and possibly use in humans. Using a multidisciplinary approach, the goals of this grant proposal are to address some of the critical research gaps in this area and to address the following questions specifically raised in the Request for Applications: 1) what are the characteristics of the range of smokeless tobacco products in current use and how do these products impact user behavior; 2) what are novel and the best measures of smokeless tobacco use, behavior and exposure; 3) what are some of the determinants of smokeless tobacco use; 3) and finally what are novel approaches that may lead to reduction of prevalence (cessation) of smokeless tobacco use. Study 1 Goal: To examine the relationship between brands of U.S. smokeless tobacco (ST) products that contain different levels of tobacco specific nitrosamines (TSNAs), other carcinogens and nicotine, and biomarkers of exposure and effect (e.g., cardiovascular risk factors). Additionally, to examine factors that influence the extent of toxicant exposure and effect besides the levels of toxicants in the product. The population will be recruited to represent different amounts of regular ST use. Importance: This study is critical in demonstrating the variability in toxicant and nicotine uptake across the various brands of ST products in order to provide evidence to support the need to reduce toxicant levels in ST products and a reference for the extent of reduction that is feasible. This study is also important for testing new or infrequently tested biomarkers (total NNN, nitrosamino acids, 1-hydroxypyrene and 4-hydroxy-1-(3- pyridyl-1-butanone (HPB) releasing hemoglobin adducts) that can be used to assess ST products. The availability of valid biomarkers of exposure and effect is critical for future tobacco regulation. This study will also provide a systematic and comprehensive examination of factors other than toxicant levels in the product that may influence exposure levels, an area of research that is novel and untested. Finally this study will provide information on toxicant burden or potential harm based on toxicity and market shares of the various products. Primary Aims: 1. To determine the toxicant exposure associated with currently marketed oral tobacco products with varying levels of tobacco specific nitrosamines (TSNAs) and nicotine. 2. To determine if toxicant and nicotine exposure is related to product factors such as the levels of these constituents in the products and patterns of use such as tins per week, dips per day and duration per day. Secondary Aims: 3. To determine if exposure is moderated by individual factors such as degree of dependence, nicotine metabolism, negative affect and stress, amount of alcohol use and perception of ST harm and environmental and social factors such as use among their social network, cost of the product and bans on tobacco use. 4. To estimate the overall toxicant burden in the population by examining the extent of carcinogen exposure of the products that have the greatest market shares. Approach: ST users (N=600) who use different brands of ST that represent a range of toxicant and nicotine levels and have sufficient market share (e.g., Kodiak Wintergreen, Grizzly Long Cut Wintergreen, Copenhagen Fine Cut, Skoal Long Cut Straight, Timber Wolf Long Cut Straight, and Skoal Bandits) will be recruited into this study. Subjects will be recruited to represent a broad range of tins of ST use, and from different regions of the U.S. (Oregon, West Virginia, and Minnesota). Subjects will attend two clinic visits for assessment and collection of blood and urine samples. Samples of ST brands will be sent to the Centers for Disease Control for constituent analyses. Hypotheses: 1) ST users will vary in their uptake of toxicants and total nicotine equivalents dependent on the brand of ST; 2) This variability will also be predominantly a function of amount of toxicants in the tobacco product and pattern of use; 3) Extent of toxicant exposure will be influenced by individual, environmental and social factors with greater dependence, faster nicotine metabolism, longer duration of use, greater negative affect and stress, greater alcohol use, perception of less ST associated harm, less cost, fewer or no bans and greater use among the social networks associated with greater tobacco use and exposure; 4) The overall toxicant burden for users would be highest for products with the greatest market share since these products tend to be the most toxic. Study 2 Goal: To determine the effects of switching ST users to brands with lower TSNA and varied nicotine content on pattern of use, dependence and biomarkers of exposure and effect, and continued tobacco use in ST users. Importance: The WHO Tobacco Regulation Study Group and many other tobacco control researchers and policy makers are advocating for reducing the toxicants in cigarette products. However, few groups have addressed reducing toxicant levels in ST products and the impact of this reduction. Furthermore, there has been limited information on whether maintenance or reduction in nicotine levels in tobacco products would lead to the greatest reduction in toxicant exposure. Reducing nicotine levels may provide a method to reduce the prevalence of use by reducing the addiction to nicotine and thereby facilitating abstinence. On the other hand, this approach may result in compensatory tobacco use and lead to a clinically insignificant reduction in toxicant exposure. The proposed research will determine the level of nicotine in ST products that will lead to the greatest reduction in toxicant exposure. Primary Aims: 1. To determine if switching to ST products with reduced toxicant levels will result in reduction of biomarkers of exposure and toxicity. 2. To determine the nicotine levels of ST that would lead to the greatest reduction in tobacco toxicant exposure. Secondary Aim: 3. To determine the extent to which varying low nicotine ST products leads to compensatory tobacco use. Approach: ST users (N=300, 100 in each condition) who are interested in switching to products that may lead to reduction in tobacco toxicants will be recruited into the study from Minnesota and Oregon. Only ST users who use products with NNN plus NNK greater than 10 μg per gram dry weight and nicotine levels between 5-7 mg/g dry weight will be recruited. Subjects will be assessed during their use of usual brand and then randomly switched to one of three ST products: 1) NNN plus NNK of about <7.5 μg/gram and nicotine levels of > 5 mg/g dry weight; 2) NNN plus NNK of < 7.5 μg/gram and nicotine levels of 3-4 mg/g dry weight; 3) NNN plus NNK of < 7.5 μg/gram and nicotine levels of < 1 mg/g dry weight. Subjects will be asked to use the products for 12 weeks. All subjects will be encouraged to quit at the end of 12 weeks, however, subjects are free to continue using the ST product or switch back to their usual brand. Subjects will be followed at 13 and 26 weeks. Hypotheses: 1) ST users who switch to lower TSNA products will experience lower toxicant uptake; 2) Subjects who switch to the lowest nicotine containing products will eventually reduce their ST use and more individuals will choose to quit using ST, leading to the greatest reduction in toxicant exposure compared to the other conditions; 3) Subjects in the moderate nicotine reduction condition will engage in significant compensatory tobacco use behavior (e.g., longer dip duration, greater number of dips per day).